Developmental and Mentoring Core

PROJECT SUMMARY/ABSTRACT
Developmental and Mentoring Core (Core B)
The goal of the Harvard University (HU) CFAR Developmental and Mentoring Core is to catalyze cutting edge
HIV research at Harvard and its affiliated hospitals through direct grant funding of projects that enhance the
CFAR mission and align with the research priorities of the OAR. Our Core focuses on leadership development
through funding and mentoring of Early Career Investigators. The Core provides developmental funding, grant
writing mentorship, and training in high priority scientific areas to support the next generation of HIV
researchers. The foundation of our funding mechanisms is the Developmental Awards, awarded twice yearly to
meritorious Early Career Investigators. To respond to developing HIV research priorities, as defined at our
annual Strategic Planning Meeting and by the OAR, the Core also releases requests for proposals to catalyze
new areas of research represented by our Scientific Working Groups (SWGs). We also sponsor and coordinate
workshops to develop critical new HIV research skills in areas that have included microbial genomics and
computational biology, enhancing the ability of CFAR members to engage in emerging research areas and
technologies. Our mentoring activities provide both intensive individual feedback, for example, through mock K
reviews prior to each NIH HIV/AIDS funding deadline, as well as broader community skill-building such as
through our K Writing and our CFAR sponsored Physician-Scientist Workshops.
The mission of the Developmental and Mentoring Core remains central to the HU CFAR, and the enormous
value of this Core has been broadly recognized at an institutional level: The Harvard Provost and the Deans of
Harvard Medical School and the Harvard T.H. Chan School of Public Health, as well as affiliated Harvard
hospitals all contribute funding support for Developmental Grants that further leverage the CFAR. In the last
funding cycle, we reviewed 221 grant applications and funded 67, for a 30% funding rate. Sixty-six percent of
grantees were women and 12% were under-represented minorities. To continue to provide high-impact,
rigorous training and mentorship for Early Career Investigators, we propose the following Specific Aims:
1) To support high-priority, cross-disciplinary HIV research activities at Harvard University and with
international colleagues through Developmental Awards; 2) To facilitate the development of new experimental
approaches in high-priority research areas as directed by the Scientific Working Groups and Programs; 3) To
foster leadership development of Early Career HIV Investigators through a mentoring program that provides
grant writing support and structured workshop skills training.